ARIZONA PRIDE-25: TRANSLATIONAL APPROACHES TO HEALTH DISPARITIES IN THE LUNG

ARIZONA PRIDE-25: “TRANSLATIONAL APPROACHES TO HEALTH DISPARITIES IN THE LUNG”
Despite significant advances in the understanding, prevention, detection, and treatment of myriad health
conditions, significant differences in prevalence rates, health outcomes, access and quality of care are
pervasive in individuals from racial and ethnic minorities and other underserved communities. These health
and healthcare disparities represent a major challenge to achieving a healthy nation status. The Arizona
PRIDE-25 Translational Approaches to Health Disparities in the Lung will enhance diversity and capacity for
health disparities solution-focused research among early career health science academics who come from
under-represented backgrounds, including minority groups and persons living with disabilities. We propose a
year-long program designed to support junior faculty and transitioning postdoctoral fellows by offering: inter-
professional mentoring and career/leadership development activities; funded research project-based
experience; grantsmanship and scientific writing training; and an individualized didactic curriculum that
integrates research methodology and analysis for translational sciences applications to the solution of health
disparities in lung conditions. The program offers participation in two summer sessions linked by a year-long
effort that integrates team mentoring, research development and implementation experience, and distance
learning inter-professional team-science career development and education program. The summer sessions
will include introduction to aspects of lung related health disparities research, coupled with garnering
experience, didactic training and skill building through direct involvement with diverse funded researchers who
are leaders in lung health disparities within the University of Arizona Health Sciences (UAHS) and external
partners. Through a combination of onsite training and online delivery modalities, mentees will receive formal
instruction in advanced biostatistics, including health economics and big data analysis from molecular, EHR,
and population health sources, all tailored to the individual's need and research content. UAHS faculty will
introduce AZ-PRIDE mentees to grantsmanship, bioethics, scientific writing, presentation workshops, and
special topics such as global, border and Native American health. Issues relevant to career development and
leadership training will be tailored to address specific needs of individuals from backgrounds traditionally
underrepresented in biomedical research (UBR). AZ-PRIDE program will continue to expand its impact as a
nationwide facilitator of academic opportunities and development for early career UBR investigators. The result
will be sustained reductions in health disparities through impactful basic, behavioral, clinical, and social
sciences research and an impactful increase in the proportion of successful next generation UBR research
leaders.

Public health relevance
Project Narrative. Existence of inequities in health and healthcare in disadvantaged populations in Arizona and the rest of the country are a major problem. The dearth of racial/ethnic and disability representation among health science researchers who work in lung disorders has become a critical and urgent challenge. The University of Arizona Health Sciences is dedicated to actively address these issues and embraces the opportunity to lead in these efforts. The “AZ-PRIDE Translational Approaches to Health Disparities in the Lung” training program is designed to help address these problems by increasing the number of well-trained early career faculty from institutions across the country that will be positioned to contribute to research geared to resolve health and healthcare disparities. It includes support created by and for people from diverse backgrounds, and experts who serve diverse communities. AZ-PRIDE will encourage program participants to commit their careers to research in lung health, and will give them tools to be successful and positioned to make impactful contributions to science. Part of the program includes formal training in writing competitive research proposals and preparing scientific manuscripts and presentations. It will also include training in advanced methodological techniques and culturally competent work with communities that will help them carry out research that can help solve health disparities. Very importantly, participants will work closely with mentors doing research in areas of interest to them, and prepare for collaborative research using a team format.